AMPK activates calcium signaling necessary for endothelial barrier repair

Project Summary: Endothelial repair subsequent to inflammation-induced vascular damage is a poorly understood process. In this application, we propose a novel role for adenosine monophosphate kinase (AMPK) in promoting cadherin adhesion assembly critical for endothelial repair. We hypothesize that AMPKα1 and N-cadherin function in tandem as a rapid response mechanism allowing pulmonary microvascular endothelial cells (PMVECs) to repair barrier disruptions quickly and limit increased capillary permeability. AMPK is most frequently described as a metabolic sensor that maintains ATP levels during periods of metabolic stress. However, recent studies indicate that AMPK also acts as a feedback mechanism that counters the destabilizing effects of elevated [Ca2+]i by promoting protein-protein interactions that strengthen cell-cell junctions. Thus, in this parallel signaling manner, an initially barrier disruptive Ca2+ signal can secondarily activate protective mechanisms. This application expands on this idea of time and location dependent Ca2+ signaling to suggest a novel role for AMPK in Ca2+ dependent cadherin adhesion assembly and barrier repair. Our preliminary results indicate that membrane associated AMPKα1 subsequent to activation by inflammation-induced Ca2+ entry, activates a discrete Ca2+ entry mechanism. This Ca2+ pathway, in contrast to inflammatory Ca2+ signaling, reorganizes the cytoskeleton crucial for N-cadherin adherens' junction assembly and endothelial cell-cell adhesion. Specifically, our preliminary data indicate capillary-derived PMVECs selectively express the AMPKα1 catalytic subunit, and pro-inflammatory challenges increase its expression in the alveolar/capillary segment in-vivo. We utilized shRNA techniques to inhibit AMPKα1 activity and observed an attenuated increase in Ca2+ induced by the inflammatory mimetic thapsigargin suggesting AMPK activated a discrete Ca2+ pathway. Moreover, AMPK inhibition blocked wound resealing in PMVECs. AMPK α1 co-immunoprecipitates with the adherens junctional protein N-cadherin and co-localizes with N-cadherin to regions of cell-cell contact in PMVECs suggesting AMPKα1 and N-cadherin function in concert to regulate cytoskeletal mechanisms necessary for establishing lung capillary endothelial integrity. This proposal tests the overall HYPOTHESIS that AMPK α1 forms a functional membrane complex with N-cadherin essential for pulmonary endothelial barrier repair. Specific Aims test the related hypotheses that: [1] AMPKα1 at the membrane forms a functional complex with N-cadherin necessary for establishing cell-cell adhesion in PMVECs.[2] AMPKα1 activates a discrete Ca2+ entry mechanism that promotes N-cadherin adhesion in PMVECs. [3] Inflammatory stimuli, through Ca2+ signaling, initiate AMPKα1 mediated PMVEC repair.

Public health relevance
Project Narrative: Endothelial dysfunction results in disruption of cell-cell adhesions leading to vascular damage and edema formation. Our research indicates that AMPKα1 functioning in tandem with N-cadherin forms a rapid response system necessary for endothelial barrier repair. Insight gained from this research can be directly applied to development of clinically applicable vascular therapies.